Thin Filaments and Muscle Regulation

Thin filament-linked actin-binding proteins, troponin and tropomyosin, control actomyosin-based muscle
contraction in cardiac and skeletal muscles. To elucidate mechanisms of muscle thin filament function at a
fundamental molecular level, it is crucial to determine the changing structural interactions of these regulatory
proteins that control muscle cooperative activation and relaxation via allosteric communication pathways between
filament components. It follows that disease-related myofibrillar protein mutants can perturb muscle on-off
switching by causing an imbalance in troponin-tropomyosin interactions on actin which, in turn, destabilizes relaxed
or active states and the transitions between them. It is our premise that early stage intervention to correct such
imbalances is paramount in diminishing or reversing resulting inexorable disease progression. In the current work,
we will address these imbalances by taking a multifaceted structural approach to elucidate the mechanism of thin
filament regulation and thus establish root causes of these perturbations. To accomplish this goal: 1. We will use
cryo-electron microscopy, coupled with 3D-image reconstruction, to establish regulatory transitions of troponin and
tropomyosin as well as test the impact of myosin-binding on thin filament actin and tropomyosin. 2. We will refine
this experimental approach with computational tools that we have pioneered to bring cryo-EM structures even
closer to an atomic level using protein-protein docking protocols and molecular dynamics. 3. We will compare
structural interactions that occur in normal thin filaments with those in filaments containing mutant proteins linked
to myopathies in order to assess how mutation-linked aberrant physiology can link to myopathology, while
localizing druggable target pockets at protein-protein interfaces. To achieve our aims, (1) we will focus on
identifying structural domains at the interface between of troponin subunit-T and actin-tropomyosin (Specific Aim
1); (2) we will reveal the structural mechanism used by regulatory domains of troponin subunit-I to trap tropomyosin
in its relaxed-state position on actin (Specific Aim 2); (3) we will determine the impact of myosin structural
interactions on actin-tropomyosin, less recognized but significant effectors of thin filament regulation (Specific Aim
3). The influence of myopathic-linked mutations in troponin, tropomyosin, actin and myosin will not only be predicted
and tested structurally but assayed functionally by measuring in vitro motility and contractility in engineered heart
tissue. Aiming to develop tools to counteract regulatory imbalances, we collaborate with associates at the Boston
University Central for Molecular Discovery to identify small molecules to be trapped at druggable interfaces along
thin filaments in order to potentially manipulate cooperative, regulatory pathways. Thus, our work on the molecular
regulation of cardiac and skeletal muscle thin filaments and muscle contraction lies at the intersection of basic and
translation biomedical research. Here, our overarching goal is to couple understanding of atomic level mutational
“insults” that alter muscle control mechanisms to prospects of reversing early-stage defects in physiological function.

Public health relevance
Project Narrative Our goal is to elucidate the mechanisms governing the regulation of cardiac and skeletal muscle contraction at a fundamental molecular level by determining the atomic structures and changing interactions of muscle proteins that control muscle activation and relaxation. A complete understanding of muscle regulatory switching mechanisms is essential to define how mutations linked to the muscle control proteins perturb muscle activation and relaxation and then lead to cardiomyopathies and skeletal muscle disease. In turn, our atomic level structures provide a platform to design compounds that specifically target the control proteins to modulate muscle activation or relaxation and thus will be able to reverse initial stage pathophysiology and delay or treat disease progress and symptoms.